Project 1 - Molecular Genetics of Human Papillomavirus Infection and Oncogenesis

PROJECT 1 − SUMMARY/ABSTRACT
A subset of human papillomaviruses (HPVs) cause 5% of human cancers including the majority of cervical
cancers. Over the current funding period, we discovered that interactions between the cervical epithelium and
its stromal tumor environment are key to cervical carcinogenesis. We will test specific hypotheses for how the
tumor microenvironment contributes to cervical carcinogenesis. We will also evaluate the role of mutations in
cellular genes in cervical carcinogenesis based upon insights gained from The Cancer Genome Atlas initiative,
and identify mutations in cancer related genes that cause cervical cancers arising in FA patients to become
HPV-independent. In the second aim we will continue utilizing the recently discovered mouse papillomavirus
MmuPV1 to investigate the role of high risk cutaneous HPVs in neoplastic skin disease, as seen in patients
with epidermodysplasia verrucoformis, using powerful new mouse models for that disease developed in our
labs. We will also study the importance of immunosuppression and epithelial progenitor cells in papillomavirus
induced skin disease.

Public health relevance
PROJECT 1 − NARRATIVE Papillomaviruses cause 5% of human cancers. In this project, we will investigate the interplay between viral and host factors in the development of these cancers in order to develop new approaches to prevent and treat papillomavirus-induced disease.